High-End Biological Atomic Force Microscope

Project Summary
This is a re-submission of the proposal “High-End Fluorescence Biological Atomic Force Microscope” of 2020
NIH S10 program (Application Number: 1 S10 OD030401-01) focusing on mechanobiological studies, a rapidly
growing field of research on the influence of mechanics in biological systems. To study mechanobiology at the
molecular, cellular, and tissue levels, researchers need a tool that can measure and control the mechanics of
samples while monitoring biological activities within the samples. The instrument requested in this proposal is
an integrated system that positions an atomic force microscope (AFM) on top of a fluorescence microscope,
providing unique capabilities to precisely measure and apply forces and simultaneously visualize biological
phenomena. The AFM platform offers force measurements, high-resolution mechanical property mapping, video-
rate imaging, and a nano-fluidics integrated probe system. The fluorescence microscope includes a spinning
disk confocal, total internal -reflection fluorescence (TIRF), and differential interference contrast (DIC). The PI
and the respective manufacturers will integrate the two systems to set up a combined platform (Bio-AFM) that
can perform advanced and simultaneous mechanical and optical measurements in real time, providing novel
approaches for mechanobiological studies of a broad variety of target bio-systems.
Access to the Bio-AFM will immediately advance the research of 16 users (10 major and 6 minor) from 5
universities and 11 departments, including 9 users funded by the NIH (> $12M in the past 5 years) and 6 users
funded by NSF, Air Force, Navy, and Army research programs. Progress in those initial projects will advance
research on neuron disorders (6 projects), the biophysics of atheroma and microvascular disease (3 projects),
biomedical materials (3 projects), mechano-sensing and its application in immunology (2 projects), bone-related
disorders (1 project), and bio-sensing for diagnostics (1 project).
The Bio-AFM will be housed in a well-established core facility where it will be accessible to everyone that needs
it. The Surface Science Core Facility currently serves more than 230 end users from more than 70 research
groups. The existing infrastructure for instrument training, operation, and management is easily adaptable to
accommodate the Bio-AFM. The PI is the Surface Science Core Facility’s founding Director (with more than 20
years of AFM research experience) and will be responsible for overseeing all Bio-AFM activities at the facility.
The Bio-AFM, like all other instruments in the Surface Science Core Facility, will be fully supported by the
institution with regard to finances, safety, outreach, IT, grant management, and administration. Given the
expertise, infrastructure, and institutional supports, the requested Bio-AFM will not only benefit the initial 14 users,
but also provide new opportunities to countless future users and new projects for biomedical research extending
far beyond the end of the grant period.

Public health relevance
Project Narrative Mechanical interactions are surprisingly important in many bio-systems. In order to study mechanobiological interactions at the molecular, cellular, and tissue levels, we are requesting a high-end fluorescence biological atomic force microscope, which is able to perform simultaneous mechanical measurements and fluorescence imaging in real time.